Caspase-8 as a focal hub in effector-triggered immunity

PROJECT SUMMARY/ABSTRACT:
Bacterial secretion system effectors are essential for the virulence of many bacterial pathogens, and a number
of effector proteins block key immune signaling pathways. However, these effectors or the alterations they
cause can also be sensed by the innate immune system. For example, effector mediated modifications of host
proteins can be recognized as pathological and trigger immune responses, a process known as effector-
triggered immunity (ETI). While ETI was first discovered in plants, it is now clear that ETI is a common defense
mechanism that is a major driving factor in the constant arms race between host and pathogens. Knowledge
about these processes is central to understanding bacterial virulence as well as host defense.
Conventional inflammasomes are multi-molecular complexes that control caspase-1 and/or 11-mediated
pyroptotic cell death and maturation of inflammatory cytokines IL-1b/IL-18. Gasdermin D (GSDMD) was
recently shown to be a key mediator of inflammasome triggered pyroptosis by cleavage at residue D276 by
caspase-1/11, and the released N-terminal fragments create a pore in cell membranes compromising
membrane integrity. These pores are also linked to IL-1β and IL-18 release. Infection of macrophages with
pathogenic Yersinia spp., causative agents of plague and gastroenteritis, trigger cell death as well as IL-1β/IL-
18 release. We have previously described a novel unconventional inflammasome pathway, requiring RIP1
kinase and caspase-8, which are typically associated with apoptotic death, that control cytokine release and
macrophage cytotoxicity after Yersinia infection. Specifically, the Type III secretion system (T3SS) effector
YopJ strongly activates caspase-8 and drives this unconventional pathway. Thus, Yersinia is an excellent
physiologically relevant model system to investigate the role of caspase-8 in the context of bacterial infection.
In particular, our supporting data indicate that YopJ inhibition of TAK1 and IKKβ kinases activates caspase-8
and induces a non-canonical inflammasome pathway, that is not dependent on caspase-1 or -11. Similar
responses are observed when inhibiting TAK1 and IKK activity, mimicking YopJ action. We show that GSDMD
is cleaved at D276 and activated by Yersinia in a caspase-8 dependent manner and that GSDMD strongly
regulates cell death and IL-1β/IL-18 release. These findings lead us to hypothesize that Yersinia YopJ
triggers a novel effector-mediated immune response, via RIPK1 and caspase-8, leading to GSDMD
cleavage, cell death and IL-1β release. How RIPK1 and caspase-8 are activated and how these events
activate GSDMD are critical questions addressed herein

Public health relevance
PROJECT NARRATIVE: This proposal contains experiments designed to determine a molecular pathway involved in the host responses to infection with Yersinia bacteria. We will study a molecule called Gasdermin D, which participates in responses leading to inflammation and cell death upon exposure to Yersinia and other bacterial pathogens.